Using the Transdermal Patch for Buprenorphine Induction during Pregnancy: A Pilot Randomized Controlled Trial

PROJECT ABSTRACT
The prevalence of opioid use disorder (OUD) during pregnancy is rising, increasing the incidence of severe
maternal, neonatal, and obstetrical morbidity and mortality. Although maternal OUD can be effectively treated
with buprenorphine, leading to improved adherence to prenatal care and reduced obstetrical complications,
fewer than 1 in 5 patients receive medication treatment for maternal OUD. In large part, so few pregnant women
receive buprenorphine because it can be challenging to initiate effectively. Initiation (termed buprenorphine
induction) must begin while a patient is in moderate withdrawal. If induction begins too early, buprenorphine will
displace the other opioid from the μ receptor, precipitating severe withdrawal. Maternal withdrawal, both
precipitated and anticipated, is associated with high relapse rates, non-adherence and lower treatment retention
rates. Unsurprisingly, induction is a known critical time point for dropout in OUD treatment. Multiple alternative
protocols for buprenorphine induction have been reported, including successful methods that do not require an
opioid-free period or moderate withdrawal symptoms by using microdoses of buprenorphine, such as via a
transdermal patch, as a bridge induction method to full sublingual doses. However, buprenorphine induction
protocols have never been studied in pregnancy to determine the most effective type. We propose a prospective,
mixed-methods study at two OUD-specific prenatal clinics to evaluate the feasibility of conducting an randomized
controlled trial (RCT) comparing buprenorphine transdermal bridge induction versus standard sublingual
induction in pregnant patients with OUD. In Aim 1, we will qualitatively assess feasibility domains using semi-
structured interviews with 20 patients using buprenorphine to treat maternal OUD, 10 clinical team members
who treats them, and 5 research team members. We will present the RCT protocol to interviewees, and ask for
feedback on consensus-based criteria of recruitment capability, assessment procedures, and acceptability. We
will
solutions,
ask interviewees to conduct a “premortem” exercise to predict potential etiologies of RCT failure, brainstorm
and adapt the RCT protocol accordingly. In Aim 2, we will quantitatively assess intervention and
research methods feasibility (eg, percentage of recruitment/retention goals, success of masking, intervention
fidelity) and preliminary efficacy to minimize withdrawal symptoms by conducting a pilot RCT of bridge versus
standard buprenorphine induction to treat maternal OUD (n=20 per arm). Results will provide preliminary data
to aid in design of large, multi-site trial powered to rigorously assess the efficacy of induction methods on
important obstetric and neonatal outcomes. If this larger trial shows that the bridge buprenorphine induction
protocol is effective in multiple populations, this treatment protocol could be widely disseminated to improve
outcomes for patients with maternal OUD and their infants.

Public health relevance
PROJECT NARRATIVE A major barrier to treatment for maternal opioid use disorder (OUD) is the buprenorphine induction process, which requires moderate withdrawal symptoms and is a critical timepoint of treatment dropout. A bridge induction method using a transdermal buprenorphine patch may be an efficacious method to minimize withdrawal symptoms and increase induction success. We propose a prospective, mixed-methods study at two OUD- specific prenatal clinics to evaluate the feasibility of conducting a randomized controlled trial comparing buprenorphine transdermal bridge induction versus standard sublingual induction in pregnant patients with OUD.